5/14 APOL1 Long-term Kidney Transplantation Outcomes Network (APOLLO) Clinical Center

ABSTRACT
The Columbia-Penn Clinical Consortium APOLLO-CC05 brings together an experienced
multidisciplinary team of clinical investigators with expertise in the fields of transplant
epidemiology, immunology, and genetics, as well as an extensive history of collaboration with
the United Network for Organ Sharing (UNOS) and other CPCC member transplant programs.
As a result, the CC05 is well suited to recruit and retain patients for longitudinal follow up for the
APOL1 Long-term Kidney Transplantation Outcomes Research Network (APOLLO) Phase 2.
This Clinical Center is composed of 11 transplant centers in four contiguous states (NY, NJ, CT
and PA) in the Northeastern US. Our primary objective is to provide long-term follow up data on
all APOLLO Phase 1 participants while continuing to enroll new African American or Black
Hispanic living kidney donors (Aim 1). We will provide detailed clinical data (not currently
available in any registry dataset) with the goal of identifying “second hits” and collect additional
biospecimens (Urine albumin to creatinine ratio, blood, urine and biopsy slides) for Aim 2. We
will partner with the SDRC to provide return of APOL1 genotype results to all participants who
wish to receive them (Aim 3). We expect that Phase 2 of the APOLLO study will determine the
impact of APOL1 risk variants in donors and recipients on kidney transplant outcomes and will
create a unique cohort of African American living kidney donors with detailed clinical data and
biospecimens as a resource for future studies.

Public health relevance
PROJECT NARRATIVE APOLLO-CPCC (CC05) comprises 11 clinical centers in the Northeastern United States. To support the APOLLO Consortium’s goal of enrolling all US kidney transplant recipients who received kidneys from African American donors as well as all African American living donors, we will build upon the infrastructure and collaboration we created in Phase 1. In Phase 2 we will leverage these relationships and resources to ensure continued recruitment of African American living donors, clinical data capture, and collection of urine albumin- to-creatinine ratio, biopsy slides and biospecimens (blood and urine) in accordance with the goals of the Consortium during the proposed follow up period.